Teachable Moment to Opt-Out of Tobacco (TeaM OUT): A Stepped Wedge Cluster Randomized Trial

Background: Cigarette smoking is the leading cause of preventable disease in the U.S. Despite decades of
slowly declining cigarette use, many older adults still actively smoke. Among Veterans, 22% overall and 17% of
those over 50 years old actively smoked in 2015. It is notoriously difficult to quit, despite widespread
knowledge among adults about the health hazards of persistent smoking and a frequent desire to quit. Given
the prevalence and persistence of tobacco addiction, the U.S. Preventive Services Task Force (USPSTF)
recommends that health care professionals offer cessation interventions at every health care encounter.
Significance/Impact: The Teachable Moment to Opt-Out of Tobacco (TeaM OUT) intervention is specifically
designed to increase motivation to quit, reduce roadblocks, and increase access to smoking cessation
resources. It is especially focused connecting older active smokers not yet ready to quit to smoking cessation
services. TeaM OUT has the potential to result in more frequent and longer periods of abstinence from
smoking in this hard-to-reach population.
Innovation: TeaM OUT combines a teachable moment with an opt-out, proactive approach to connect patients
to existing cessation services using interactive voice response (IVR) technology. IVR is a proactive and
affordable way to reach more older active smokers more frequently.
Specific Aims: Aim 1: Among patients recently diagnosed with a pulmonary nodule, evaluate the
effectiveness of a proactive, teachable moment-based, smoking cessation outreach intervention (TeaM OUT)
on increasing engagement with smoking cessation resources compared to Enhanced Usual Care. Aim 2:
Evaluate the association of receipt of TeaM OUT with nicotine abstinence (seven-day point prevalence and
biochemically-measured) and quit motivation compared to Enhanced Usual Care. Aim 3: Qualitatively elicit
perspectives from key stakeholders to inform acceptability and utility, implementation barriers and facilitators,
and scalability of TeaM OUT.
Methodology: In aim 1, we use pulmonary nodule registries to identify participants from three VA facilities (VA
Portland, Minneapolis VA, Charleston VA). Patients with pulmonary nodules will be contacted after a stepped-
wedged randomization at the clinical level. Participants in the intervention arm are called by the IVR Quitline,
whereas participants the control arm must proactively choose to call the quitline. Options selected on the
quitline will be recorded and analyzed using logistic regression to test if the quitline increases engagement with
smoking cessation services. For aim 2, a subsample of participants in aim 1 will be contacted to complete
additional surveys for 56 weeks after nodule identification. We will measure nicotine abstinence, quit
motivation, and communication and analyze the measures using multivariable, multi-level hierarchical logistic
regression. In aim 3, we will qualitatively assess TeaM OUT by interviewing patient participants twice during
the study – first at the time of the initial Proactive IVR contact and second at 13 months after enrollment.
Clinical stakeholders will also be interviewed, with a focus on current and desired smoking cessations and
experiences with the TeaM OUT intervention. Codes will be derived without preconceived categories.
Next Steps/Implementation: We have purposely designed the intervention and overall study to maximize
generalizability, feasibility, adoption, and sustainability of the intervention. We plan multiple scientific
presentations and publications. Investigators will attend annual American Thoracic Society and HSRD
conferences to present the research findings. We will place all de-identified data in our IRB-approved Health
Services Research Repository (IRB #3535) at the conclusion of the study. We are creating a detailed toolkit as
part of the study's implementation process so that the IVR system can be easily replicated in multiple settings.

Public health relevance
Among Veterans over 50 years old, 17% actively smoke cigarettes. Teachable Moment to Opt- Out of Tobacco (TeaM OUT) is a smoking cessation intervention designed to make use of interactive voice response (IVR) technology in order to engage with patients during a possible teachable moment: the discovery of a pulmonary nodule. This project will evaluate whether a pragmatic, proactive, low-cost solution, that takes advantage of a naturally occurring teachable moment, can increase smoking abstinence in this group as well as provide generalizable results for patients in multiple settings and situations.